HLS-Applying EpiX™ technology to enable ex vivo theratyping using nasal brushing samples from CF patients

Project Abstract (Topic code HLS18-02) Signiﬁcant progress has been achieved in developing precision therapies for cystic ﬁbrosis (CF); however, highly effective treatments that target the cystic ﬁbrosis transmembrane conductance regulator (CFTR) are not yet available for every patient with CF. Therapeutic efforts have recently focused on correcting the defect resulting from the common F508del variant, as well as many less frequent missense alleles. Of the missense variants, more than 500 have been noted in 10 individuals or fewer worldwide. The rarity of these patients precludes standard randomized controlled trials to test efﬁcacy of new CFTR therapeutics in the clinical pipelines. Thus reliable in vitro cell-based models capable of predicting drug efﬁcacy using patient-derived cells to support individualized treatment plans and translational research are essential. Primary human nasal or bronchial epithelial cells have emerged as strong predictive tools to study rare CFTR variants in a near-native context. Despite their outstanding value, primary nasal or bronchial epithelial cells are difficult to grow and expand using conventional cell culture media, impeding their employment in evaluating CFTR-targeted precision therapy. Here we propose using our patented EpiX™ cell culture technology to expand airway epithelial cells from nasal brushing samples of CF patients for in vitro human cell-based models to predict individual responses to CFTR-directed therapeutics. EpiX™ medium allows over trillion-fold of in vitro expansion like the conditional reprogramming method, without using feeder cells. The expanded cells can be seamlessly integrated into existing downstream differentiation protocols and put into physiological CFTR and mucociliary functional evaluations. EpiX™-expanded bronchial epithelial cells maintain CFTR and epithelial sodium channel (ENaC) functions even after trillion-fold expansion. EpiX™ also supports quick and efficient expansion of a small number of basal epithelial cells, such as those derived from nasal brushing samples, to generate hundreds of millions of cells. The EpiX™ medium provides a reliable, robust and easy- to-use solution that offers significant advantages over current technologies that related to the ultimate goals to identify personalized therapy for CF patients.

Public health relevance
Project Narrative on Relevance to Public Health The most common chronic and lifespan-shortening genetic disease afflicting the lung is cystic ﬁbrosis (CF). Overall, there are over 30,000 people in the United States with CF, and more than 90,000 CF patients worldwide. One in 3,000 Caucasian newborns are diagnosed with the disease. Since 2012, two drugs have been approved by the FDA to treat the underlying chloride channel defect in CF. One of the drug, Kalydeco (ivacaftor) is approved to treat CF patients with one of 33 mutations in the CFTR gene, which accounts for about 10% cases of CF. A second drug, Orkambi (lumacaftor-ivacaftor) has been developed to treat patients with the more common homozygous F508del/F508del CFTR mutation, but clinical gains are modest and adverse side effects have forced some patients to stop taking this medication. Both drugs cost hundreds of thousands of dollars per patient per year in the United States, which represents $10–15 million over the life of an average patient with CF. More than 2,000 variants within CFTR have been observed to date. Of the missense CFTR variants, more than 500 have been noted in 10 individuals or fewer worldwide. The rarity of these patients precludes standard randomized controlled trials to test efﬁcacy of new CFTR therapeutics in the clinical pipelines. Moreover, CF patients with the same CFTR mutation exhibit substantial variation in severity of lung disease due to the variations in patients’ genetic make-up. A drug targeting the same CFTR mutation may result in a range of responses, with some individuals showing significant clinical improvement while others have little to no response. Reliable in vitro cell-based models capable of predicting drug efﬁcacy using patient-derived cells could help to identify which drug or drug combinations would benefit individual patient the most. Such personalized precision therapy could reduce public health cost significantly.